Group 1 Metabotropic Glutamate Receptor’s Influence on T Cells During Chronic Toxoplasma Infection

PROJECT SUMMARY/ABSTRACT
Toxoplasma gondii (T. gondii) is one of the most effective transmissible pathogens in the world, infecting
approximately two billion people. Encystment of the parasite in neurons in the brain results in a lifelong chronic
infection. Within the brain, a pro-inflammatory response is essential to prevent parasite reactivation. Infection in
the immunocompromised leads to lethal toxoplasmic encephalitis while in the immunocompetent, there is
persistent low-grade inflammation which lacks clinical symptoms. This suggests that there is a tightly regulated
inflammatory response to T. gondii in the brain. T cells are the dominant immune cell that control
recrudescence and parasite replication through secretion of effector molecules such as perforins and IFN-γ.
However, little is known on how these cells are regulated in this tissue. During chronic infection there is an
increase in extracellular (EC) glutamate. High EC glutamate is not specific to T. gondii infection and can occur
during multiple pathologies but may be an important environmental signal to tissue specific immune cells. We
hypothesize that this glutamate-rich environment plays a role in T cell function and regulation.
Preliminarily data demonstrate that T cells from the T. gondii -infected brain express the G-protein coupled
metabotropic glutamate receptors (mGluR’s), mGluR1 and mGluR5. This expression is enriched in T cells
recruited to the brain compared to secondary lymphoid derived cells. This project aims to: 1) define group 1
mGluR expressing T cells in the brain during infection, and determine if there is a functional difference
compared to the periphery. This will be done by characterizing surface proteins for canonical T cell subsets,
testing the secretion of effector molecules, defining if they localize to distinct regions of the brain, and
characterizing the transcriptional profile at a single cell level; 2) determine how group 1 mGluR’s regulate T
cells in response to infection. This will be done by tracking adoptively transferred mGluR-deficient T cells in an
infected wild type recipient, and by activating or inhibiting these receptors ex vivo, followed by measuring
changes in viability, proliferation, cytokine production, and canonical Gq molecules; 3) determine if lowering the
glutamate concentrations in the infected brain will alter the T cell recruitment profile to the central nervous
system (CNS). This will be done by characterizing mGluR expressing T cells recruited to the brain after
ceftriaxone treatment, an antibiotic previously used in our lab to lower exogenous glutamate in the brain by
increasing glutamate transporter-1 expression. Overall, this proposal will help us understand how tissue-
derived signals influence protective immunity. Furthermore, what we learn from our proposed studies could be
broaden to other fields such as neurodegenerative research, as some of these neurological maladies not only
have a commonality of glutamate alteration, but also a recruitment of T cells to the CNS.

Public health relevance
PROJECT NARRATIVE The ultimate goal of this research is to determine the influence of glutamate on the protective immunity exerted by T cells in response to chronic toxoplasma infection. This research would contribute to our fundamental knowledge of how tissue-derived signals modify the immune landscape, as well as, have broad implications in other areas of disease research that implicate both changes in glutamate concentrations, and a recruitment of T cells into the central nervous system. Furthermore, understanding how glutamate regulates T cell function and signaling through metabotropic glutamate receptor modulation would set the foundations for generating potential therapeutic targets for manipulating T cells.